Primary Immunodeficiency Diseases Consortium Conference

DESCRIPTION (provided by applicant): This grant requests support for travel grants to be provided to presenters for attending the 2009 Primary Immunodeficiency Diseases Consortium Conference. This grant will provide funding to support travel for the participants and assist with program development. Additional funding will be solicited from pharmaceutical and biotechnology companies. This program, which is co-organized with the USIDNET, is scheduled to take place just prior to the Federation of Clinical Immunology Societies (FOCIS) Annual Meeting. The program will be advertised on websites from the Clinical Immunology Society (CIS), FOCIS, the American Academy of Allergy, Asthma &Immunology (AAAAI), the European Society of Immunodeficiency (ESID), and the USIDNET. In addition to posting this information on their web sites, they will also send out notices to their membership advertising the Consortium. This activity is intended to reach an international target audience consisting of fellows-in-training, junior faculty, as well as noted experts in the field. This Consortium plans to bring together experts in the field to discuss recent updates as well as material related to our understanding of the scientific processes affected in various primary immunodeficiencies. Both by lecture and networking during the symposium, clinicians and researchers will come away with an improved knowledge of primary immunodeficiencies. The material will be delivered primarily in lecture format, but there will also be a poster session and scheduled breaks to allow networking, mentoring, and one-on-one time with the state-of-the art lecturers. The objectives for this conference are to continue to advance understanding of the diagnosis, molecular defects, complications, and treatment of these complex diseases;to develop the careers of new scientists in this area of academic medicine;to enhance awareness of clinical immunology and its importance in scientific discoveries and clinical applications;and to stimulate future collaborations between investigators in different medical centers and countries, and between new investigators and experienced physician-scientists in the field. The mission of the Primary Immunodeficiency Diseases Consortium Conference is to bring together experts from around the world to discuss diagnosis, pathogenesis, and management of diseases which are often uncommon at any one institution. The emphasis will be on recent advances in the understanding of primary immunodeficiencies. The proposed Primary Immunodeficiency Diseases Consortium Conference will bring together experts in the field to discuss recent updates as well as material related to our understanding of the scientific processes affected in various primary immunodeficiencies. This symposium will enhance knowledge of physicians and basic researchers in the field but will ultimately lead to improved patient care.

Public health relevance
Narrative The proposed Primary Immunodeficiency Diseases Consortium Conference will bring together experts in the field to discuss recent updates as well as material related to our understanding of the scientific processes affected in various primary immunodeficiencies. This symposium will enhance knowledge of physicians and basic researchers in the field but will ultimately lead to improved patient care.